Reward Responsiveness as a Prevention Target in Youth At Risk for Anhedonia

PROJECT SUMMARY
Anhedonia, a core symptom of depression and other forms of psychopathology characterized by loss of
interest or pleasure, is associated with a range of negative health outcomes, including suicide risk, and poor
treatment response. Low activation of positive valence systems, particularly low reward responsiveness (RR),
is a key brain-behavioral process underlying anhedonia. Critically, there is growing evidence that low RR is
observable in children at risk for anhedonia due to maternal symptomatology and reflects a vulnerability for the
later emergence of anhedonia and depression. Thus, targeting RR in high-risk children is critically needed to
prevent the development of anhedonia, alter risk trajectories, and mitigate the tremendous health burden of
anhedonia-related psychopathology. Combining principles from adult positive affect treatment and family
cognitive behavioral preventive interventions, we developed an innovative, neuroscience-informed dyadic
preventive intervention, Family Promoting Positive Emotions (F-PPE), for 8- to 12-year-old children and
mothers with a history of major depressive disorder with anhedonia. F-PPE is designed to specifically target
RR in children, assessed at the neural level using well-validated electroencephalogram methods. The first
phase of the project (R61) will focus on target engagement, testing whether F-PPE increases child neural RR
relative to an active comparison. Children (N=60) will complete neural measures of RR pre-intervention, 4-
weeks into the intervention to determine dose effects, and post-intervention (8 weeks). Biological mother-child
dyads will be randomized to F-PPE or a psychoeducation preventive intervention comparison. Target
engagement will be defined as an increase in neural RR in the F-PPE relative to psychoeducation group with
at least a medium effect size (d > .40). Change in the target at 4 weeks will be examined to determine dose
effects and integrated with participant feedback to refine F-PPE for the R33 phase. The R33 phase will be a
replication and extension to clinical outcomes with 100 biological mother-child dyads. Dyads will again be
randomized to F-PPE or a comparable number of psychoeducation sessions. In addition to neural RR,
ecological momentary assessment of real-world experiences of interest and pleasure and clinical symptoms of
anhedonia will be assessed pre- and post-intervention and at a 6-month follow-up assessment. We will
examine effects of F-PPE on momentary experiences of interest/pleasure and symptoms of anhedonia across
the longitudinal follow-up and test change in RR as a mechanism of clinical effects of F-PPE. These projects
will take critical next steps in translating developmental affective neuroscience research to prevention and
moving towards precision medicine to reduce the burden of anhedonia and associated psychopathologies.

Public health relevance
PROJECT NARRATIVE Anhedonia, a core symptom of depression and other forms of psychopathology associated with severe negative health outcomes, including suicidality and poor treatment response, is a major public health concern. We will test an innovative positive emotion-focused preventive intervention for children and mothers with a history of major depression with anhedonia to enhance child reward responsiveness and prevent the emergence of anhedonia in youth. This study will advance understanding of how affective neuroscience can be translated into an experimental therapeutics approach to prevention, leading to more personalized interventions to reduce the burden of anhedonia and associated psychopathologies.